TREATMENT OF PULMONARY MYCOBACTERIUM TUBERCULOSIS AND HIV INFECTION

The goal of this study is to compare the effectiveness of different intermittent induction and continuation therapies, in two distinct areas, for the treatment of tuberculosis in HIV-infected individuals. (ACTG 222)